Role of Structural Remodeling in Atrial Fibrillation

7. Project Summary
Current treatments for persistent atrial fibrillation (AF) are associated with high recurrence rates due to our limited
understanding of how AF develops and sustains. In patients with AF, structural remodeling in the form of fibrosis
is often present, indicating that structural remodeling may have a role in AF development. This project aims to
identify the role of fibrosis in AF by using a transgenic goat model. In aim 1, we strive to show the importance of
structural remodeling compared to electrical remodeling in AF developing. In aim 2, the architecture of structural
remodeling will be investigated to identify if differences in the underlying fibrotic architecture lead to increased
AF susceptibility. In aim 3, the fibrotic architecture will be compared to in-vivo electrical mapping data to
determine how varying degrees of fibrosis affect conduction patterns. The results of this project will investigate
if there is a causal relationship between structural remodeling and impaired conduction. Success in this project
will lead to improved ablation targets for patients with persistent AF, leading to lower recurrence rates.
Completing this project provides valuable scientific and technical training to develop into an independent
researcher.

Public health relevance
8. Project Narrative Atrial fibrillation is the most common cardiac arrhythmia globally, and arises from chaotic electrical activity in the atria. Currently, treatments for atrial fibrillation still have a high recurrence rate due to our limited understanding of how atrial fibrillation develops and sustains. The goal of this project is to investigate the role of structural remodeling in atrial fibrillation, through high-density in-vivo electrophysiology mapping and high-resolution ex- vivo imaging on a transgenic goat model, to improve our understanding of how atrial fibrillation develops.